Decipher the Molecular Mechanisms of Breast Cancer Bone Metastasis

Breast cancer (BCa) metastases are associated with extremely high mortality; hence, the development of
effective prevention and treatment strategies for metastatic breast cancer is critical. Bone is typically the first and
most frequent site of breast cancer metastatic expansion, and the resulting metastases can cause severe pain,
immobility, fractures, and nerve damage. Additionally, our recent studies underscore the important role bone
metastases can play in spreading cancer cells to other organs, thus making the bone metastatic process a very
attractive target for the prevention and treatment of metastatic breast cancer. Presently, current treatments for
bone metastases, such as bisphosphonates, have shown limited success, largely because these drugs
predominantly target bone turnover and remodeling instead of directly eradicating cancer cells in the bone
environment. Moreover, tumor cells can at times survive adjuvant therapies given to patients after surgery and
eventually cause late-onset relapse in bone. It is therefore imperative to establish new therapeutic strategies to
improve the outcome of patients with breast cancer bone metastases.
Our preliminary studies are helping to unravel the transition of biological behaviors from the early phase of
bone metastases (termed microscopic-bone metastasis or micro-BoM) to established BoM (termed macro-BoM).
At the micro-BoM stage, the colonized metastatic tumor cells grow slowly and undergo amino acid and lipid
metabolism to collect and accumulate necessary resources to sustain their survival. Our mechanistic studies
have suggested that in the micro-BoM stage, the transcriptional coactivators YAP/TAZ are regulated by a bone-
specific calcium-signaling-related mechanism, and YAP/TAZ activation orchestrates a repertoire of metabolic
gene expression. Furthermore, we have developed delicate strategies that allow us to treat the microscopic bone
lesions. The overall objectives of this proposal are to understand the underlying molecular mechanisms by which
YAP/TAZ activation drives the advancing of BCa BoM. Our central hypothesize is that YAP/TAZ orchestrates an
evolution of metabolic behaviors in micro-BoM and targeting of YAP/TAZ could potentially impede cellular
adaptation processes and arrest the progression of micro-BoM. Our long-term goals are to decipher the crosstalk
between YAP/TAZ activation in bone-colonized tumor cells and the bone microenvironment and uncover new
therapeutic targets to treat both the microscopic and fully established BoM. To achieve these goals, we propose
the following two aims: 1) determine the molecular mechanisms driving the dynamical activation of YAP/TAZ in
BCa BoM; 2) determine the functional role of YAP/TAZ-activation-driven metabolic reprograming in BCa micro-
BoM. A major impact of this study will be the identification of previously undescribed mechanisms underlying the
adaptation and progression of microscopic BoM that can inform the development of new biomarkers and novel
therapeutic interventions for advanced or metastatic BCa.

Public health relevance
Bone metastases (BoM) are particularly prevalent in breast cancer (BCa) and represent an attractive focus for research aimed at improving survival rates and quality of life in advanced BCa patients. Current clinical treatments are inadequate with only minimal benefits on survival and quality of life, and there are currently no curative treatment options. By investigating a newly discovered role of YAP/TAZ molecular events in the orchestration in early stage of BCa BoM, we will advance our understanding of the evolutional processes underlying the progression of microscopic-BoM and reveal new therapeutic strategies for advanced BCa patients with bone lesions.